DP24-004, PRC Core: Center for Health Promotion and Disease Prevention

ABSTRACT
Diabetes affects over 37 million people in the US with the disease burden disproportionately borne by
American Indian, African American, Hispanic/Latino, and rural subgroups (our priority populations). Despite
progress in diabetes treatment, glycemic and cardiometabolic (e.g., blood pressure) outcomes are not
improving. Healthy eating, physical activity, medication adherence, and self-monitoring of blood glucose are
essential self-care practices. While Diabetes Self-Management Education and Support (DSMES) programs are
effective at improving these self-care practices, they are significantly under-utilized nationwide, with only 5% of
newly diagnosed Medicare beneficiaries and 6.8% with private insurance accessing DSMES within one year of
diagnosis. Innovative implementation strategies are needed to bridge the gap between research and practice.
Prevention Research Centers (PRC) are well positioned to lead this effort. We propose building on our long
experience in the PRC Network to: 1) continue growing our prevention research capacity; 2) support a core
research project to identify more effective strategies for implementing, scaling, and sustaining DSMES, with a
focus on eliminating health disparities/inequities; and 3) contribute to and learn from PRC Network partners to
improve public health service delivery in partnership with state and local health departments; community and
tribal organizations; and national organizations. Together, we will put feasible evidence-based interventions
into national practice, addressing health equity as the highest priority.
Our core research project will focus on understanding how to implement DSMES more equitably in those at
highest risk by examining contextual factors and key drivers of DSMES utilization, such as reimbursements,
referral policies/practices, and willingness of persons with diabetes (PWD) to participate. We propose a 3-
phase study to address implementation challenges for rural residents in NC with high diabetes prevalence.
Phase I: Understand complex determinants of uptake and sustained DSMES use in priority populations
to adapt program delivery. Use systems and implementation science to understand barriers and facilitators
of DSMES uptake, prioritize key leverage points for change, assess organizational readiness for DSMES
implementation, and identify cultural adaptations for DSMES materials.
Phase II: Test the effects of adapted DSMES program implementation. Use a hybrid trial Type 3
effectiveness-implementation design (12 sites: 6 health departments + 6 Federally Qualified Health
Centers/similar primary care clinics and 240 PWD [20 participants per site]).
Phase III: Disseminate and translate research products to state and national audiences through
established partnerships and stakeholder support. With program staff and PWD, conduct a final review of
the adapted DSMES to anticipate and address potential implementation, dissemination, and translation
challenges and develop a DSMES Toolkit companion guide and marketing plan for widespread dissemination.

Public health relevance
PROGRAM NARRATIVE Diabetes affects over 37 million people in the US and the biggest impact is on American Indian, African American, Hispanic/Latino, and rural populations. Although Diabetes Self-Management Education and Support (DSMES) programs are known to improve health outcomes, these programs often fail to reach those who suffer most from this disease. We propose a project to understand the barriers to DSMES uptake and sustained use among underserved populations in order to improve how we deliver DSMES so that more people with diabetes across the country can improve their health.